Molecular Characterization of Progressive Pulmonary Sarcoidosis

PROJECT SUMMARY
Pulmonary involvement occurs in up to 90% of sarcoidosis cases, the disease course is heterogeneous and
respiratory failure is the leading cause of sarcoidosis-related mortality in the US. Most studies undertaken to date
in sarcoidosis compare cases to healthy or disease controls. There are knowledge gaps in the understanding
of sarcoidosis subtypes including the underlying molecular features, biologic pathways and mechanisms of
progressive pulmonary sarcoidosis disease progression. As a result, there are no clinical tools available for early
prediction of progressive (P) sarcoidosis to allow closer clinical follow-up, early treatment and to provide focus
for research. The goal of this project is to enroll sarcoidosis patients to define molecular characteristics of P-
sarcoidosis that will (a) enable early identification of patients at higher risk of progression. To develop tools for
rapid identification and prediction of P-sarcoidosis progression, this project will investigate molecular signatures
(proteins and genes ) and related biological pathways identified in a laboratory model of sarcoidosis granulomas
and in peripheral blood mononuclear cells (PBMCs) of patients with P- vs non-progressive (NP)- sarcoidosis. (b)
provide insights into the different biological mechanisms driving outcomes in pulmonary sarcoidosis. Our
promising pilot data identified protein and transcriptional pathways engaged during granulomatous inflammation
and in PMBCs in proxies of P- and NP-sarcoidosis. Aim 1 builds on preliminary findings, characterizing
differences in P- and NP-sarcoidosis protein and gene pathways, leveraging the unique granuloma model. We
include single cell-RNA-Sequencing in a subset of cases with innovative digital cytometry methods to obtain cell-
specific pathways. Aim 2 will define pathways and signatures from PBMCs, which are recruited and contribute
to granuloma development and persistence as well as features that are shared and distinct from the model. Aim
3 will leverage findings from PMBCs and the in vitro model and clinical disease manifestations using innovative
bioinformatics approaches to construct and internally validate a comprehensive classifier that incorporates
proteins, clinical variables and patient-reported outcomes in a Discovery Cohort. The investigators will validate
this classifier in an independent Validation Cohort of subjects already enrolled by the research team in prior NIH
funded studies. The study uses novel approaches to characterize P-sarcoidosis and a diverse research team
led by MPIs with complementary expertise. The integration of sarcoidosis investigators from different locations
across the country will advance and sustain the sarcoidosis research through highly innovative translational
studies implementing state-of-the-art clinical and biological systems-level studies in a high-priority area of
research in sarcoidosis. These studies will provide the foundation for future studies aimed at evaluating this
classifier in longitudinal and patient care studies to identify an at-risk sarcoidosis population that may require
closer follow up and earlier treatment, and research pertaining to the identification of novel mechanistic pathways
and therapeutic targets contributing to P-sarcoidosis.

Public health relevance
PROJECT NARRATIVE The reason why some patients develop progressive lung involvement in sarcoidosis, have unrelenting symptoms and worsening lung function and others don’t, is not well understood. This proposal will define factors that may explain why some people get progressive sarcoidosis while also establishing new proteins, genes, markers and a potential tool to detect persistent or progressive lung inflammation and worsening lung function. In future studies, these factors may be tested clinically as tests or predictors of disease and ultimately even targets for therapy.